The Postpartum Assessment of Women Survey (PAWS): Informing Medicaid Policies to Improve Health in the "Fourth Trimester"

PROJECT SUMMARY
The year after birth, also known as the “fourth trimester”, is a growing focus of efforts to address high rates of
maternal morbidity and mortality in the United States (U.S.), which disproportionally affect racial-ethnic
minorities, rural women and women insured by Medicaid at delivery. More than half of pregnancy-related deaths
occur in the year after delivery and a significant share of women experience postpartum morbidity due to physical
and mental health conditions. As the payer for nearly half of U.S. births and a larger share of births among Black
and Indigenous women, Medicaid is a key lever to improve population-level postpartum health disparities. As
the COVID-19 pandemic subsides, policymakers are considering a range of Medicaid policy changes—alone
and in conjunction with other social policy sectors—aimed to improve postpartum health, such as extending
pregnancy Medicaid one year postpartum or addressing social risk factors. Yet, the determinants of postpartum
wellbeing and health disparities are poorly understood. This is largely because the fourth trimester has been
a neglected focus of maternal health policy and research.
To drive evidence-based policymaking and fill the significant gap in high quality, representative data on
postpartum health, our multidisciplinary team developed a large-scale follow-up survey administered one year
after birth in collaboration with six states and New York City: the Postpartum Assessment of Women Survey
(PAWS). The 2020 PAWS captured the postpartum experience of women who gave birth in 2020, during the
height of the public health emergency (PHE). This proposed project leverages and builds on this first-of-its kind
data collection effort to respond to the urgent needs of policymakers to improve postpartum health in the new
public health, policy and social context that will emerge as the pandemic subsides, as the policies and protections
of the PHE end, and as new policies begin (e.g. postpartum Medicaid extensions in 2022). Specifically, we will
launch a new PAWS survey round following a 2023 birth cohort (data collected in 2024) to measure (1) maternal
health outcome disparities in the postpartum year (by insurance, race-ethnicity, and urban/rural residence), (2)
health care-related disparities and their contribution to disparities in postpartum health outcomes, and (3) social
and economic disparities and their contribution to disparities in postpartum health outcomes.
Drawing on expertise from our diverse, interdisciplinary team of junior and senior investigators, and in deep
collaboration with state and city government partners, we will produce a highly valuable scientific resource
and generate timely, rigorous findings to inform evidence-based policies with the potential to advance
maternal health equity in the U.S.

Public health relevance
PROJECT NARRATIVE The year after birth, also known as the “fourth trimester”, is a growing focus of efforts to address high rates of maternal morbidity and mortality in the United States, which disproportionally affect racial-ethnic minorities, rural women and Medicaid beneficiaries. Yet, high-quality evidence on postpartum health and wellbeing and the drivers of postpartum health disparities is severely lacking. This project will address this important gap by collecting and analyzing rich multi-state survey data on the health and social needs of postpartum women in the year after birth, producing data of high scientific value with the aim to identify mechanisms that could be targeted to reduce postpartum health disparities.